DNA-based assay for calorimetric determination and quantitation of protein concentrations in pure or mixed solutions

Abstract
An attractive feature of using in vitro expression systems to generate biological compounds is the
capability to produce a wide variety of compounds (proteins, peptides, antibodies) on various scales, in a
cheap and rapid manner. Current methods to analyze any of these produced compounds require
purification which poses a major drawback for working with products derived from expression systems.
For example, a moderately abundant (soluble) protein can require 27 individual steps over four days to
purify; a significant amount of time and expense to screen a single protein. Screening a library of potential
biological compounds for therapeutic value, requires many purification steps for each compound before
any analysis can be performed. This includes measurements as simple as determination of the mass of
the produced biological compounds. To this end we have developed a unique DNA-based scheme using
differential scanning calorimetry for determination of the masses of biological compounds in both purified
and mixed media. Uniquely, our probes are universally applicable to a wide range of biological compounds
enabling mass quantification prior to purification. This advance allows for initial analysis of biologics early
in the production process, lowering associated time requirements and resource costs. An added benefit
is the possibility to supplant the numerous mass analysis kits currently on the market that rely on
colorimetric or fluorescent methods. These methods are highly specific to the types of compounds
assayed and have limitations preventing universal applicability. Our product offers a superior advantage
of existing methods. In this project we plan to screen a library of biologically expressed SARS-CoV-2 spike
and nucleocapsid proteins generated by our commercial collaborator. The aim of this work is to evaluate
whether our assay is capable of predicting protein yields from their expression systems solely from a mass
determination of their unpurified samples. Additionally, we will use our assay to verify the protein
structure before and after purification.

Public health relevance
Project Narrative Production of many biopharmaceuticals or biologics, low abundance and engineered molecules is accomplished using prokaryotic or eukaryotic expression systems; allowing for the manufacture of a large variety of biological compounds on a small scale for screening applications, and large scale on the metric-ton scale for therapeutics. However, while expression of the targeted biological compounds is cheap and fast, a major drawback is the time required and expense involved in purification and isolation of targeted compounds. We have developed an assay that will allow quantitative analysis of proteins prior to purification; in this project we will screen biologically expressed SARS-CoV-2 proteins from a commercial collaborator for validation studies.